Leadership, Planning, and Evaluation

LEADERSHIP, PLANNING, AND EVALUATION (LPE): PROJECT SUMMARY
The Wake Forest Baptist Comprehensive Cancer Center (WFBCCC) Leadership, Planning, and Evaluation is
an essential multi-level process that identifies strategic opportunities, performs ongoing evaluation, and develops
Center initiatives. The Cancer Center Director establishes the vision for the WFBCCC with input from the Senior
Leaders and feedback from the various planning and evaluation activities and committees. WFBCCC’s vision is
to be a preeminent leader in advancing the understanding of cancer through research innovation, discovery, and
translation into innovative therapies and prevention strategies through exemplary collaboration and community
engagement. WFBCCC’s mission is to reduce cancer incidence, morbidity, and mortality along the rural
southeast Appalachian region of the United States, as well as nationally and internationally, through cutting-edge
research and treatment, community education and outreach, and transdisciplinary training of next-generation
biomedical scientists and healthcare providers. Implementation is guided by a well-developed Strategic Plan,
which was informed by Cancer Center stakeholders, including its advisory bodies, the Institution, the community,
and Center members. Planning and evaluation activities address both the strategic priorities and Center
operations. They also thoroughly assess program goals, transdisciplinary and translational research, community
outreach and engagement, education and training development, strategic recruitment, pilot project support, the
clinical trial portfolio, and accrual strategy. The strong commitment to planning and evaluation activities has been
critical to WFBCCC’s achievement of its strategic goals. The process relies on both internal and external boards.
Internationally renowned translational researcher and WFBCCC Director, Boris Pasche, MD, PhD, leads a team
of eight Associate Directors who comprise his Senior Leadership team. They contribute their unparalleled
expertise, vision, and strategic planning skills to mobilize the support required to bring initiatives to fruition. Senior
Leadership comprises the Executive Committee, which is the primary research advisory body for WFBCCC that
makes mission-critical recommendations to the WFBCCC Director for all facets of the Cancer Center related to
research. It reviews the progress and future directions of the research programs, shared resources, and other
components of the Cancer Center Support Grant. In addition to his Senior Leadership, Pasche relies upon the
following major advisory mechanisms for input and advice: the External Advisory Board, comprised of outside
experts who provide essential independent and objective evaluation and advice for the WFBCC; the Community
Advisory Board, which advises the Center on effective ways to integrate community engagement into clinical,
research, and educational activities, with the goal of reducing cancer burden in the catchment area; and the
Internal Advisory Board, made up of Institutional leaders, which advises the Center on optimal coordination of
resources and how to align Cancer Center priorities across the enterprise and the community it serves.